Neural Mechanisms underlying Obesity-induced Taste Dysfunction

PROJECT SUMMARY
A key driver of the obesity epidemic is the excessive consumption of highly palatable, calorie-rich foods.
Obesity, in turn, leads to substantial alterations in taste sensitivity and food preferences, perpetuating
the obese state. However, the neurobiological underpinnings of the interaction between obesity and
taste sensation remain largely uncharted. The overall objective of this application is to determine how
the brainstem neurons that convey taste information are impacted by obesity. To achieve this, we
propose studies to identify obesity-dependent changes to taste neurons at the circuit-, cellular- and
molecular-level. In the long-term, we envision that these studies will reveal platforms for therapeutic
intervention aimed at disrupting the self-perpetuating cycle of overconsumption in obesity.

Public health relevance
PROJECT NARRATIVE Obesity is a global health crisis, associated with significant mortality rates and healthcare costs. However, insights into how obesity impacts eating behavior is lacking. To address this pressing need, the proposed study aims to investigate the neurobiological changes to the taste sensory system resulting from obesity.